Dissecting the role of serine metabolism in stem cell fate and tissue regeneration

Project Summary/Abstract
Tissue stem cells stem cells of the epidermis protect us from external insults, grow hair, and repair wounds.
Extensive characterization of epidermal stem cells (IFE-SCs) and hair follicle stem cells (HFSCs) has uncovered
how their transcriptional and signaling pathways regulate regeneration. Far less is known about how stem cells
incorporate metabolic inputs, which can profoundly affect the balance between proliferation and differentiation.
When regeneration is slowed in wound repair, it can be detrimental and lead to hyperproliferative states
associated with inflammation and malignancy. Therefore, a knowledge of how metabolism impacts the
regenerative capabilities of stem cells will fill a critical knowledge gap and an unmet and pressing need for new
ways to promote tissue regeneration and wound repair. Furthermore, it may provide novel avenues to curb
inflammation and metastatic cutaneous squamous cell carcinomas (SCCs).
Serine is an attractive candidate for therapeutic intervention, as we know that SCC cells become addicted to
serine uptake to avoid serine biosynthesis and production of the metabolite a-ketoglutarate (aKG). To be able
to clinically translate these findings, we must understand how serine impacts normal HFSCs and their two
regenerative processes: 1) HF regeneration, which involves lineage specification, and 2) wound healing, where
HFSCs re-epithelialize epidermis and undergo a fate switch to the IFE-SC lineage. These two processes entail
different stem cell fate decisions and demonstrate different responses to histone modifications. Given the
importance of aKG in regulating histone modifications and its accumulation upon exogenous restriction of serine,
I hypothesize that serine metabolism controls stem cell fate decisions in both wound healing and hair
regeneration via aKG-dependent histone demethylase enzymes (KDMs).
My preliminary data demonstrated a striking acceleration in wound repair upon dietary serine/glycine
restriction, which results in increased de novo serine biosynthesis. I also observed a marked reduction in the
histone mark H3K27me3, implicating activation of aKG-dependent KDMs. Thus, in Aim 1, I will first test whether
dietary serine and glycine restriction controls HF regeneration. In Aim 2, I will test whether the effects of serine
and glycine restriction on HF regeneration and wound repair are HFSC-autonomous. In Aim 3, I will test whether
dietary ser/gly restriction alters the histone modification and chromatin accessibility landscape and dissect the
underlying mechanism behind it. I expect these studies to 1) provide the first direct evidence of whether serine
metabolism controls endogenous stem cells during tissue regeneration, 2) inform novel therapies to promote
wound repair, and 3) enable dietary or metabolic interventions in the prevention and treatment of SCC in ways
that do not harm normal regenerative processes.

Public health relevance
Project Narrative While a great deal is known about how the transcriptional and signaling pathways that regulate the stem cell response to tissue regeneration, it is currently unknown whether stem cells integrate metabolic inputs into this process. Based on previous studies and my preliminary data, I propose that serine metabolism controls stem cell fate decisions during tissue regeneration. Successful completion of my aims will be of particular utility to promote wound repair and possibly enable dietary or metabolic interventions in the prevention and treatment of SCC in ways that do not impair normal regenerative processes.